Phosphodiesterase 1 (PDE1) Regulation of Myocardial Calcium and Function

Project Summary
The body has innate mechanisms to increase cardiac function under varying physiologic conditions. Inotropes,
a class of heart failure drugs, utilize these mechanisms to therapeutically improve cardiac function. Some
inotropes, however, are safe while others increase the risk of side effects like arrhythmias. This is an intriguing
question when considering two drugs that improve heart function by inhibiting phosphodiesterases (PDEs).
PDE inhibition mechanistically increases cyclic nucleotide cAMP levels and thus activate protein kinase A
(PKA) cell signaling pathways in the heart. Pharmacologic inhibition of PDEs 1 or 3 augments cardiac function.
Chronic PDE3 inhibition (PDE3i), however, increases fatal arrhythmias in patients. While the arrhythmogenic
effects of chronic PDE1i remains unknown, acute inhibition is safe. We do not yet fully understand how PDE 1
or 3 inhibition mechanisms differ to explain these differences. The goal of this study is to uncover fundamental
cardiac contractility mechanisms that distinguish the actions of the two inotropes. We test the central
hypothesis that appropriate compartmentalized control of cAMP/PKA signaling will accomplish specified
improvement in cardiac contractility. This is supported by our prior findings that PDE3i activated PKA signaling
to increase L-type calcium channel (LTCC) and the sarcoplasmic reticulum (SR) calcium load, but that PDE1i
selectively augmented LTCC activity. And while β-blockers abrogated the inotropic effects of PDE3i, the effects
for PDE1i persisted. In preliminary data, we show that sarcolemmal cAMP is predominantly hydrolyzed by
PDE1 in living myocytes. Furthermore, PDE4, but not PDE1, inhibition synergistically increase cAMP that is
produced upon β-adrenergic receptor stimulation. The investigation of compartmentalized myocardial
contractility mechanisms in health and disease will be divided into three aims. In Aim 1, we will delineate cyclic
nucleotides-activated pathways downstream of PDE1 inhibition that increase LTCC function. This will be done
using biosensors of cAMP, cGMP, and PKA in isolated myocytes using Forster resonance energy transfer
(FRET) imaging. LTCC function will be tested using patch clamping. Healthy, heart failure guinea pigs, and
genetically modified mice will be used. Aim 2 will investigate the role of cell excitation and calcium cycling as
mechanisms for PDE1i inotropy. We will test ion fluxes across the sarcolemmal membrane and SR combining
patch clamping and confocal imaging using calcium indicators in guinea pig myocytes. Finally, in Aim 3 we will
evaluate the arrhythomogenic effects of long-term PDE1i and expose any potential mechanisms in comparison
to chronic PDE3i. Healthy or heart failure guinea pigs treated with PDE1 or PDE3 inhibitor will undergo ex vivo
optical mapping mechanocoupling study or serial, conscious electrocardiogram study using telemetry device.
PDE1i has completed clinical evaluation in heart failure patients. Thus, understanding how these PKA
signaling pathways differ will critically guide future trial designs. Moreover, using rational design from the
knowledge this study produces, we can refine the next generation of inotropes and other heart failure drugs.

Public health relevance
Project Narrative Heart failure drugs help improve cardiac performance. This study compares an FDA-approved drug with a promising new drug to answer why one drug might cause irregular heart rhythms as a fatal side effect while another is safe. The understanding of how these drugs work will reveal exciting new cell processes to enable future heart failure drug development towards increased efficacy and minimal side effects.